Lumicks C-Trap Dymo-300 for interdisciplinary research at The RNA Institute

Project Summary
The Life Science Initiative and the RNA Institute of the State University of New York at Albany (UAlbany)
represent a regional hub for multidisciplinary and collaborative research by undergraduate and graduate
students, post-doctoral fellows, research staff, and faculty. This highly interactive institution operates on a
dynamic collaborative approach toward scientific discoveries and high-quality education. To continue our
faculty’s historic interdisciplinary collaborative research ventures through our shared core research facilities, we
have identified a need for a Lumicks C-Trap correlative force and fluorescence optical tweezer system. This
unique instrument is capable of real-time observation, monitoring, and quantitation of interactions between and
within biomolecules, cells, and other nano-micro scale materials. This instrument can provide a unique window
into biological and biochemical mechanisms. Acquisition of this instrument will benefit a wide variety of research
programs across the project’s major and minor user groups encompassing diverse fields including: RNA structure
and function, RNA modifications, regulation of transcription and translation, developmental biology, nucleic acid
nanotechnology, RNA repeat disorders, viral infection dynamics, and drug development. This instrument will
bring new capabilities that are currently unavailable on campus or even within a 100+ mile radius. The excellent
capabilities of this system will enable our program’s major and minor users as well as the broader research
community of New York’s capital region to meet the imaging research needs of their cutting-edge research
programs.

Public health relevance
Project Narrative Monitoring how biological molecules and cells interact with each other is important to understanding biological processes in normal human health and in disease. Acquisition of a Lumicks C-Trap combined optical tweezers with coincident confocal microscopy will enable direct observations of such interactions to provide mechanistic insight into biological and biochemical interactions. These capabilities will transform multiple research programs spanning a diverse range of fields including RNA structure and function, regulation of transcription and translation, DNA nanotechnology, RNA repeat disorders, and drug development.